Innate immune recognition and response to Rift Valley fever virus

Rift Valley fever virus (RVFV) is widespread throughout the entire African continent and in some endemic
areas over 50% of the population is exposed by adulthood. Antiviral responses induced by interferon (IFN)
signaling can limit RVFV replication and inhibit RVFV pathogenesis in vivo. RVFV is known to infect
mononuclear phagocytic cells (MPCs), hepatocytes, and neurons, consistent with its main clinical
manifestations of acute febrile illness, hepatitis, or encephalitis. However, it is largely unknown how each of
these cell types recognizes and responds to RVFV infection or how cell type specific innate immune responses
modulate viral pathogenesis. The overall objective for this proposal is to determine how the mammalian host
innate immune system recognizes and responds to RVFV infection and how this modulates viral pathogenesis.
Our central hypothesis is that differential innate immune recognition and response by infected cells modulates
viral pathogenesis. To test this hypothesis, we will 1) identify the innate immune sensors and effectors active in
biologically relevant human primary cells, 2) define the contribution of key innate immune sensors and
effectors in recognition and response to RVFV infection in vivo and 3) define the role of hematopoietic cell
infection in RVFV pathogenesis in vivo. The results of this research will define the mechanisms of innate
immune recognition and response following RVFV infection. Moreover, it will inform on cell type-specific
responses to infection and how virally mediated antagonism of those responses contributes to viral
pathogenesis.

Public health relevance
Rift Valley fever virus (RVFV) is widespread throughout the entire African continent and in some endemic areas over 50% of the population is exposed by adulthood. Activity of the innate immune system is key to mitigating the severity of disease and the virus has actively evolved ways to abrogate innate immune function. In this project we will define how biologically relevant primary human cells recognize and respond to RVFV infection, determine which innate signaling pathways function to provide protection from disease, and define the contribution of hematopoietic cell infection to in vivo pathogenesis.